Next generation oncolytic virotherapy targeting AKT and ERK signaling in glioma

Abstract:
The overall goal of this project is to develop a novel oncolytic viral therapy for Glioblastoma (GBM). GBM is the
most lethal and frequent primary adult brain tumor with median overall survival of less than 21 months. Around
80 percent of GBM patients experience one or more seizures. Interestingly, every fourth case of GBM is
diagnosed after the first sign of seizure as the presenting symptom. We already observed seizures in our GBM
mice models and will evaluate seizure frequency in untreated and oHSV treated GBM mice as described.
Here we propose to create an Oncolytic virus that can show improved efficacy alone and in combination with
radiation and Temozolomide. Further we believe that the proposed virus may also help alleviate glioma
associated epilepsy and can improve quality of life for patients.
Oncolytic viral therapy works by lysing tumor cells as well as activating antitumor immunity. In our preliminary
results, we created an oHSV that is armed with PTENα (oP10/ oHSVP10). This virus blocks PI3K/AKT signaling
and has increased therapeutic efficacy that is dependent on T cell activation (Russell et al Nat. Commun. 2018).
Long-term survivors in this study rejected subsequent challenge and the therapeutic benefit was lost when mice
were depleted of T cells. WE have been investigating changes induced by oP10 in the tumor and tumor micro-
environment to explore opportunities to improve the therapeutic index of this virus for GBM. Our studies show
that oP10 induces secretion of Hylauronic acid, which forms the major extracellular matrix (ECM) in the brain.
To investigate the impact of this on virotherapy we have created a second virus called ox44 that can block HA
induced signaling in brain tumors. Here we will evaluate the impact of combining these two strategies on
therapeutic efficacy: Anti-tumor killing and immunity alone ( ), and in combination with radiation and
Temozolomide ( ). Our studies further show that this strategy can reduce the expression of xCT, a
Aim 1
Aim 2
transporter implicated in glutamate release. Extracellular glutamate has been shown to induce glioma growth
and epilepsy, thus we hypothesize that this strategy will reduce extracellular glutamate and also reduce glioma
induced epileptic seizures. We will thus collaborate with Dr. Deak at Augusta University to evaluate the impact
of this strategy on glioma induced epilepsy (
Aim 3
).

Public health relevance
RELEVANCE TO PUBLIC HEALTH The prognosis for GBM patients remains dismal and there is an urgent unmet need for novel therapies. The first oncolytic virus to be approved by the FDA is an oncolytic HSV whose use is prescribed for melanoma patients is HSV-1 derived. Japan has also recently conditionally approved use of an oncolytic HSV for GBM patients. Thus there is a lot of interest in developing this treatment modality. To increase the utility of this novel approach for brain tumor patients we propose to create and optimize a oncolytic HSV for therapy.